Emory Vaccine and Treatment Evaluation Unit - DMID 20-0034

Summary/Abstract The Emory VTEU has proven essential in the fight against the pandemic. This supplement will allow for further investigations into second generation vaccines trials (20-0034). 1

Public health relevance
Narrative The Emory VTEU will participate in DMID 20-0034, a phase 1 trial to evaluate the safety, immunogenicity, and reactogenicity of heterologous and homologous Chimpanzee Adenovirus and self-amplifying mRNA prime-boost prophylactic vaccines against SARS-CoV-2 in healthy adults. 1